CHRONIC TOXICITY STUDY OF COBALTOUS SULFATE

The objective of this study is to determine the chronic toxicity and carcinogenicity of Cobalt Sulfare administered by inhalation to Fisher 344 rats and B6C3Fl mice. The contract will include a Phase 1 which is the basic award and includes the preliminary atmosphere generation/monitoring effort. Phase 2 consists of a 104-Week Inhalation Study with Fischer F344 rats and B6CF1 mice treating at 3 dose levels plus controls.